Administrative Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The objective of the C-SiG Administrative Core is to provide leadership for the overall direction of the
Center and to optimize member benefits from Center Programs and Cores. C-SiG Administrative Core
leadership is provided by Dr. N. F. LaRusso, Director; Dr. G. J. Gores, Co-Director; and Dr. V. H. Shah,
Associate Director, in conjunction with an Executive Committee, an Internal Advisory Committee, and an
External Advisory Committee. The Executive Committee meets monthly and is comprised of the Director,
Co-Director, Associate Directors, Core Directors, the Leaders of the Mechanistic Research Theme groups
(Intracellular Signaling, Cellular Networks, and Genetics/Epigenetics), and key leaders within the Division of
Gastroenterology and Hepatology at Mayo Clinic Rochester who are all C-SiG members. The Internal
Advisory Committee, made up from institutional leaders, meets annually and provides regular input to the
Executive Committee regarding the strategic direction of the Center and facilitates communication with
institutional leaders. The External Advisory Committee consists of five internationally prominent
investigators who are leaders in digestive disease research and meets annually in person to review the P/F
candidate projects and by conference call as needed to provide feedback to the Executive Committee. An
Administrator, Ms. Dutton Gibbs, provides the necessary support for real-time financial management and
operations of the Center. A Core Project Manager, Ms. Trussoni, performs day-to-day Core project
management to improve standardization of core processes, streamlines efficiency of workflows, and
enhances deliverable quality. The Operations Committee consists of the Director, Co-director, Associate
Director, Administrator and Core Project Manager and meets weekly to plan and manage C-SiG operations.
The administrative leadership assures responsiveness of the C-SiG Cores to the needs of the members and
provides oversight for Core functions. C-SiG’s goals are to promote cell signaling science by: i) Fostering
multidisciplinary research by expanding technical and collaborative capabilities of established GI scientists
and attracting investigators from other disciplines; ii) Identifying and nurturing new GI investigators via a
peer-reviewed Pilot and Feasibility (P/F) Program including career development workshops, curricula, and
structured mentorship (30/42, 71% of P/F recipients achieving federal funding 2009-2023); iii) Offering
core-based specialized equipment, technologies, methodologies, reagents, and expertise (Microscopy and
Microfluidics, Clinical, and Epigenomics and Spatial Biology Cores), with continuous core menu updates
including the addition of 2 new confocal microscopes, microfluidics and spatial biology equipment and
services in response to member feedback; iv) Supporting a robust Enrichment Program; and v) Promoting
interactions between C-SiG with other NIH centers at Mayo (e.g. Center for Clinical and Translational
Science) and existing NIDDK DDRCCs, especially in the Midwest (i.e., Midwest DDRCC Alliance).